Effects of full-spectrum cannabidiol on alcohol consumption and alcohol use disorder phenotypes: implications for precision medicine

PROJECT SUMMARY
Alcohol use disorders (AUD) are a leading cause of morbidity and mortality in the US, but existing treatments
show only modest efficacy, and some have medical contraindications which limit their utility. Identification of
safe, novel AUD medications is a high research priority. Cannabidiol (CBD) has generated interest as a treatment
target due to preclinical studies showing that it reduces alcohol intake and data suggesting it is safe and well-
tolerated in humans. Human research has mainly tested pure CBD (which does not contain other components
of the cannabis plant). However, emerging data, including our own preliminary work, indicate that when CBD is
combined with a small (<1%) amount of delta-9-tetrahydrocannabinol (THC), its effects—including its ability to
reduce drinking—are enhanced. Thus, a compelling, largely unexplored potential treatment is full spectrum CBD
(fs-CBD, which contains mostly CBD, plus a small [<.3%] amount of THC and other cannabis plant components).
Notably, fs-CBD is already widely available commercially in the US and is the most popular CBD product on the
market. Thus, if it shows promising effects, it could be rapidly integrated into clinical care. The overarching goal
of this proposal is to conduct a randomized, placebo-controlled trial comparing the effects of fs-CBD relative to
broad-spectrum CBD (bs-CBD, which is the same as fs-CBD except that it does not contain THC) and placebo,
on alcohol consumption (in the lab and in the real world [Aim 1]) and on several clinically relevant AUD pheno-
types (Aims 2 and 3), among adults with AUD. Specifically, we will test effects of fs-CBD (vs. bs-CBD and pla-
cebo) on a battery of AUD phenotyping measures (corresponding to the Addictions Neuroclinical Assessment
[ANA] domains) that could aid in identifying individuals for whom fs-CBD is likely to be an effective treatment
(Aim 2) and on the gut microbiome (Exploratory Aim 3), which has been shown to play an important role in the
etiology and maintenance of AUD. No prior study has evaluated effects of fs-CBD on alcohol consumption in the
lab or explored potential mediators of its effects. We will recruit adults with AUD to be randomly assigned to take
fs-CBD, bs-CBD or placebo daily for 4 weeks, during which they will report on their alcohol use via daily surveys.
They will complete a lab session at the end of the 4 weeks involving an alcohol self-administration (bar lab) task,
ANA assessments, and a blood draw (to measure an alcohol biomarker and circulating gut markers). Participants
will provide fecal samples for assaying the gut microbiome. The ANA battery and blood and fecal samples will
also be collected at baseline, so that post-intervention change in the proposed mediators can be measured.
Given that fs-CBD is already widely used, results would have immediate public health and clinical impact. Find-
ings could also inform a precision-medicine approach (using ANA phenotyping or phenotyping based on gut
characteristics) to identify AUD patients likely to respond to CBD treatments. Finally, results will shed light on
the interaction between CBD and THC in the context of AUD and could deepen our understanding of the link
between the endogenous cannabinoid system and AUD, to provide foundational data for future research.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to conduct a randomized, placebo-controlled trial comparing the effects of hemp- derived, full-spectrum cannabidiol (fs-CBD, which contains a small amount of THC and other cannabis plant components), relative to hemp-derived, broad-spectrum CBD (bs-CBD, which is the same as fs-CBD except that it does not contain THC) and placebo, on alcohol consumption, behavioral AUD phenotypes and the gut microbiome, among adults with alcohol use disorder (AUD). Understanding whether hemp-derived fs-CBD offers benefits for AUD has tremendous public health relevance because existing AUD medications show only modest efficacy, and while pure CBD has recently garnered interest as a potential AUD treatment option, emerging data suggest that it may be more effective when combined with other cannabinoids, as in the proposed trial. Further, given that fs-CBD is the most commonly used commercial CBD product in the US (and limited research has been done testing its effects), results could have immediate public health impact and be rapidly integrated into clinical care.